SHORT TERM CLINICAL AND VIROLOGIC SIGNIFICANCE OF ZDV RESISTANCE

ACTG 194 is a randomized, double blinded study designed to determine the clinical and virologic significance of in vitro ZDV resistance in HIV-infected individuals.